Obesity Rehabilitation for Improving Walking Efficiency in Neurological Disease

Project Summary/Abstract
Multiple sclerosis (MS) is a chronic neurological disease characterized by demyelination and transection of
axons as well as loss of neurons in the central nervous system with a prevalence of approximately 2.3 million
people worldwide, and over 40% of these individuals are overweight or obese. Adults of the general population
who are overweight or obese have symptoms including worse levels of fatigue, depression, pain, and anxiety,
all of which are prevalent in persons with MS. Such a pattern suggests that the prevalence and severity of
these symptoms might actually be worse in persons with MS who have poor body composition profiles.
Furthermore, persons with MS who have poor body composition may have worse walking efficiency, indicated
by elevated oxygen (O2) cost of walking. O2 cost of walking is defined as the amount of O2 consumed per
kilogram of body weight per unit distance walked. Collectively, there is evidence that O2 cost of walking is
higher in persons with MS compared with controls and may worsen as disability status progresses. With
elevated O2 cost of walking, persons with MS may experience higher levels of fatigue and participate in less
physical activity, impeding these individuals from engaging within the community. To date, there are few
studies examining the relationship between body composition and O2 cost of walking in persons with MS. Body
mass index (BMI) has been the primary measure of body composition in research on the O2 cost of walking in
MS but significantly underestimates adiposity in persons with MS and cannot differentiate between different
tissue types. Dual x-ray absorptiometry is the standard measure of body composition and has the capability to
differentiate fat mass, fat-free mass, and bone mineral content of the overall body. To that end, the first aim of
cross-sectional design study is to examine the relationship between body composition and the O2 cost of
walking in persons with MS. We hypothesize that persons with MS who have more body fat, less lean tissue,
and lower bone mineral content will demonstrate higher levels of O2 cost of walking. The second aim is to
identify MS-related consequences (i.e., fatigue, depression, pain, and anxiety) of body composition and how
O2 cost of walking affects this relationship. We hypothesize that persons with MS who have worse body
composition will demonstrate elevated O2 cost of walking and worse consequences. This proposed research
will provide preliminary evidence to better understand the relationship among body composition, O2 cost of
walking, and MS-related consequences. These findings may guide researchers, clinicians, and exercise
specialists in the design of targeted approaches, such as exercise training, for optimizing body composition to
improve walking efficiency and manage its secondary consequences in MS with the aim to promote health and
better overall quality of life, which aligns with the PI’s research agenda of helping persons with neurological
conditions integrate or reintegrate into the community post-injury or post-diagnosis.

Public health relevance
Project Narrative There is evidence that obesity is prevalent in persons with multiple sclerosis (MS), yet there are few studies that have examined how body composition may be related to walking efficiency, indicated by O2 cost of walking, and symptoms (i.e., fatigue, depressive symptoms, pain, and anxiety) in persons with MS of varying body composition profiles. This project will provide a better understanding of whether fat mass, fat-free mass, and bone mineral content are related to walking efficiency and identify MS-related outcomes as possible correlates and consequences in persons with MS. This approach will provide preliminary evidence to guide researchers, clinicians, and exercise specialists in the design of targeted, health-promoting, lifestyle approaches for the optimization of body composition for improving walking efficiency and managing symptoms with the aim to better quality of life while living with MS.